Engaging Aging Minds: Labor Force Participation, Stimulating Activities, and Cognitive Aging Across Diverse International Settings.

PROJECT SUMMARY
Alzheimer's disease and Alzheimer's disease-related dementias (AD/ADRD) present profound global
challenges, particularly for rapidly aging populations in low- and middle-income countries (LMICs). An
important approach to mitigating dementia risk is strategies to promote cognitive function throughout life.
Research suggests that beyond formal education in childhood and early adulthood, labor force participation
and stimulating activities could provide stimulation in the middle and later years and reduce cognitive decline
and AD/ADRD. However, these findings are mostly from Western high-income countries (HICs) and may not
apply to LMICs, where prospects for older people, especially older women, are largely lacking, with few
opportunities to remain active and intellectually stimulated throughout life. Comparable data from LMICs and
HICs are needed to provide the necessary variability to observe different experiences in labor engagement and
opportunities for stimulating activities and to examine their effects on cognitive aging processes in racially,
ethnically, educationally, and culturally diverse populations. Such data could offer insights that cannot be
observed in more homogenous populations and could inform tailored policies to prevent cognitive decline and
AD/ADRD worldwide. This proposed project will address critical gaps in global cognitive aging research by
investigating the impact of labor force participation and key stimulating activities in middle and later life on
cognitive aging outcomes by gender and across sociocultural contexts. We will use data from three LMICs—
China, India, and Mexico—that represent a significant portion of the global aging population with variable
gender norms and roles and opportunities in education, work, and stimulating activities. We will contrast these
data with two developed countries, England and the US. We will leverage novel comprehensive
neuropsychological batteries in >20,000 participants from the global Harmonized Cognitive Assessment
Protocol (HCAP) studies and longitudinal data from their parent studies from diverse sociocultural contexts. We
will pursue three specific aims: 1) evaluate cross-country differences in both labor force participation and
engagement in stimulating activities and their relationships with cognitive functioning and cognitive decline by
gender; 2) evaluate cross-country differences in the relationships between labor force participation and
stimulating activities with subsequent dementia by gender; and 3) investigate within-country gender differences
in types of work and stimulating activities and their impact on cognitive decline and dementia. Results from the
proposed project will provide critical insights to inform global prevention of AD/ADRD risk—especially in LMIC
populations that are growing rapidly but most vulnerable to the challenges posed by AD/ADRD—by informing
tailored interventions and policies in the US and globally to improve population health.

Public health relevance
PROJECT NARRATIVE There is a critical need to identify modifiable factors and effective strategies throughout the life course that can promote cognitive function, delay cognitive decline, and mitigate Alzheimer's Disease and Related Dementias (ADRD) risk in diverse populations across sociocultural and economic contexts. This project will use cross- nationally harmonized data to investigate the impact of labor force participation and key stimulating activities in middle and later life on cognitive aging outcomes by gender and across sociocultural contexts. Findings from this study will provide critical insights to inform global prevention of ADRD—especially in low- and middle- income countries' populations that are growing rapidly and are most vulnerable to the challenges posed by ADRD—by informing tailored interventions and policies in the US and globally to improve population health.